Role and Therapeutic Value of AHR in Inflammatory Macrophages during GBM

PROJECT SUMMARY Neuro-inflammation and immunosuppression have a significant impact on glioblastoma (GBM). Macrophages infiltrate brain tumors, undergo modulation by the GBM microenvironment and promote the suppression of tumor-specific immunity. Signaling through the ligand-activated transcription factor Aryl Hydrocarbon Receptor (AHR) has strong effects on the regulation of the immune response and has been recently implicated in the suppression of GBM-specific immunity. However the biological mechanisms by which AHR regulates the immune response to GBM and the potential of AHR as a therapeutic target for GBM are unknown. We found that AHR controls the recruitment of inflammatory macrophages, also called glioma- infiltrating macrophages, to GBM. Moreover, we found that the specific deletion of AHR in macrophages significantly slows GBM growth. Based on these findings, we hypothesize that the AHR modulates glioma-infiltrating macrophages that suppress GBM-specific immunity. In this project, we propose to study the role of AHR in GBM-infiltrating macrophages. Our specific aims are: Specific Aim 1: Investigate the mechanism by which AHR controls immunosuppressive macrophages in GBM. We propose to 1) study the differential contribution of AHR signaling in macrophages and microglia on GBM immunosuppression; 2) investigate the transcriptional effects of AHR signaling in macrophages and microglia in GBM. Specific Aim 2: Treatment of a GBM model by targeting AHR with nanoparticles carrying AHR inhibitors. We propose to 1) investigate the effects of nanoparticles loaded with an AHR inhibitor on glioma- infiltrating macrophages in vitro; 2) determine the therapeutic effects of nanoparticles in an experimental GBM model.

Public health relevance
PROJECT NARRATIVE Macrophages play an important role in glioblastoma (GBM) progression by suppressing the anti-tumor activity of the immune system. However, the mechanisms of their pathogenicity and pathways regulating them are poorly characterized. We found that the survival of GBM-bearing mice with a specific deletion of the transcription factor aryl hydrocarbon receptor (AHR) in macrophages is significantly improved and this is associated with the reduced infiltration of GBM by inflammatory macrophages. In this project, we propose to study the role of AHR in the control of pathogenic macrophages in GBM progression, and the potential of AHR as a therapeutic target for glioblastoma and other brain tumors. __SpecificAimsTextDelimiter__ SPECIFIC AIMS: Inflammation has a significant impact on glioblastoma (GBM). Different subsets of myeloid cells, mainly macrophages, infiltrate brain tumors, undergo modulation by the GBM microenvironment and promote tumor growth by facilitating tumor cell invasion, angiogenesis, and by suppressing tumor-specific immunity [1]. Signaling through the ligand-activated transcription factor aryl hydrocarbon receptor (AHR) has been shown to promote the development of GBM [2]. The pathways by which AHR signaling affects GBM development are not understood, however it has been proposed that AHR activation suppresses tumor-specific immunity by unspecified mechanisms. AHR is an important regulator of the immune response [3]. Indeed, we were among the first to report that AHR controls the activity of T cells and cells of the innate immune system [4-10]. Considering the limited efficacy of GBM therapies, the study of the mechanisms by which AHR regulates macrophage activity has the potential to lead to new therapeutic approaches for the modulation of the immune response in GBM. Our goals are to characterize the mechanisms by which AHR controls the immune response and develop new therapeutic approaches for brain tumors. The objective of this application is to study the role of AHR in the suppression of GBM-specific immunity. Our central hypothesis is that AHR regulates the recruitment of macrophages that suppress GBM-specific immunity (Fig. 1). We formulated this hypothesis based on the following observations: 1) AHR deficiency in myeloid cells results in decreased GBM infiltration by macrophages and delayed tumor growth in vivo; 2) miR-29b down-regulates AHR expression in macrophages and other cell types; 3) decreased miR-29b expression and increased AHR expression have been previously associated with worsening of the disease in patients. Based on these observations, the focus of this proposal is to elucidate the function of AHR in glioma-infiltrating macrophages (GIMs). The specific aims are designed to understand the role of AHR in GIMs and its potential as a therapeutic target for GBM. Our specific aims are: Specific Aim 1: Investigate the mechanism by which AHR controls immunosuppressive macrophages in GBM. We found that AHR controls the survival of GBM-bearing mice and the infiltration of the GBM by CCL2-dependent immunosuppressive macrophages. These observations suggest that AHR supports GBM progression by promoting the recruitment of immunosuppressive macrophages to the GBM. To study the regulation of macrophages by AHR in GBM we propose to 1) study the differential contribution of AHR signaling in macrophages and microglia on GBM immunosuppression; 2) investigate the transcriptional effects of AHR signaling in macrophages and microglia in GBM. Specific Aim 2: Treatment of a GBM model by targeting AHR with nanoparticles carrying AHR inhibitors. Nanoparticles (NPs) have found multiple applications in medicine [11], including their use for targeted cell delivery in vivo. We recently reported the use of NPs to control the immune function of myeloid cells through AHR signaling [4]. To investigate the therapeutic potential of AHR in GBM, we propose to 1) characterize the effects of the nanoparticles loaded with an AHR inhibitor on glioma-infiltrating macrophages in vitro; 2) determine the therapeutic effects of nanoparticles in an experimental GBM model. CNS GBM GIM Kyn AHR + TDO CCL2 - NPi Periphery Treg AHR Monocyte Ly6C + CCR2 AHR - Monocyte NPi These studies will investigate the cellular and molecular immune mechanisms through which AHR controls GBM growth and will establish the potential of AHR as a therapeutic target for the modulation of GBM-specific immunity. Figure 1. Model for the effects of AHR in the regulation of GBM-specific immunity. AHR regulates the expression of CCR2 and CCL2, which mediate the recruitment of macrophages to GBM. Monocytes exposed to the GBM-derived immunosuppressive molecules, such as the AHR ligand kynurenin, egress the CNS and promote the expansion of GBM-specific FoxP3+ Tregs. Nanoparticle- delivered AHR inhibitors (NPi) are expected to interfere with the recruitment and activity of GBM-modulated monocytes.